Clinical Laboratory Core

Abstract
Substance use is associated with increased risk of, progression to, and negative outcomes from chronic
disease. Although associations between substance use disorders (SUDs) and chronic disease are well
documented, specific mechanisms underlying these associations are poorly understood and underappreciated.
Experimental studies that use placebo-controlled, randomized designs are essential for understanding
physiological mechanisms that link SUDs and chronic disease. The research and pilot projects in the Center
for Addiction and Disease Risk Exacerbation (CADRE) COBRE at Brown University will investigate
physiological mechanisms underlying the effects of opioids, cannabis, tobacco, and alcohol on risks for and
progression of SUD-related disease. Mechanisms to be studied in the initial four CADRE research projects
include systemic inflammation, immune system dysregulation, high blood pressure, pulmonary effects and
carcinogen exposure. The CADRE's Clinical Laboratory Core (CLC) will provide the current and future CADRE
research and pilot project investigators with the space, supplies, equipment, technical capability, scientific
expertise and data management/analysis expertise necessary to meet the needs of their projects. These
resources are not otherwise available at Brown, and are essential for achieving the Specific Aims of the
CADRE projects. Provision of these resources via the CLC will improve efficiency, consistency and economy of
scale across projects. Specific Aim 1 of the CLC Core is to provide resources necessary for developing and
sustaining a multi-disciplinary center focused on SUDs and chronic disease. Specific Aim 2 is to facilitate and
coordinate assay and other services provided to the CADRE investigators through neighboring COBREs.
Specific Aim 3, an exploratory aim, is to build a center-wide biobank and database of biological, behavioral and
environmental risk factors associated with the development and progression of SUDs and chronic disease.
Resources provided by the CLC will build on and complement, but not overlap, resources currently available at
Brown. The successful achievement of these aims will be a thematically- and technically-linked center that
supports the initial and future projects, enhances the competitiveness of the project leaders for independent
external funding, becomes a national leader in understanding biobehavioral mechanisms linking SUDs and
chronic disease, and serves as a resource for training and research within Brown, regionally, and nationally.